Evaluation of the SMART IBD App Digital Therapeutic Tool for Pediatric Inflammatory Bowel Disease

Project Summary
Poor disease self-management is a significant issue in pediatric IBD, with up to 88% of adolescents
demonstrating nonadherence to medication. This is a significant concern given that 1) the risk relapse in IBD is
5.5 times greater in nonadherent patients than in adherent patients; 2) the annual costs of health care in
nonadherent IBD patients can be up to 12.5% higher; and 3) the estimated annual cost of nonadherence in US
health care overall is $300 billion. We have identified numerous factors that interfere with adolescents’ ability to
demonstrate optimal self-management of their illness. Although these barriers are amenable to intervention,
many adolescents lack the self-management skills to overcome them on their own, and clinic-based self-
management efforts have proven unfeasible on a large scale. Through our intervention research in pediatric
IBD, we have developed and demonstrated the efficacy of a multicomponent self-management intervention.
However, the proportion of the IBD population that could receive this type of treatment is restricted due to
limited access (e.g., lack of available trained clinicians, distance between patient homes and treatment facility).
In collaboration with key stakeholders (i.e., patients, parents, and providers), we have addressed these
accessibility issues by iteratively developing an IBD-specific Self-Management Assistance for Recommended
Treatment (SMART) mHealth application, which can be used by all key users to address patient self-
management needs. With funding from the Clare Foundation we have adapted evidence-based content
developed via our prior R21 (HD074842) for a mobile app developed for both iOS and Android operating
systems. The SMART IBD App prompts patients to complete daily diaries assessing disease activity and
functional ability, tracks medications and symptoms, personalizes reminders for medication and appointments,
provides graphical feedback and IBD-specific education via static content and animated videos, and includes
self-management behavioral health challenges using gamification strategies. It is integrated with our electronic
medical record, Epic, so providers can access critical self-management data for treatment planning. In this
project, we will test, via a Phase IIb randomized controlled clinical trial, the effect of the SMART IBD App on
medication adherence, disease activity, functional disability, and health-related quality of life in adolescents
with IBD compared to Attention Control. A total of 70 patients and their parents will be enrolled. This study will
have a significant impact on public health by providing greater access to evidence-based self-management
support to a large proportion of patients who otherwise would not receive this intervention. Given the health
and economic impact of poor self-management in IBD, this study is timely and important, as it has the potential
to positively impact IBD adherence and health outcomes and serve as a model for self-management
intervention across pediatric populations.

Public health relevance
Narrative The purpose of this study is to test the preliminary efficacy of the “Self-Management Assistance for Recommended Treatment (SMART)” IBD App recently developed to promote better self-management in pediatric patients with inflammatory bowel disease (IBD) using evidence-based assessment and intervention. We will conduct a randomized controlled trial to test how use of the SMART IBD App affects medication adherence and health outcomes in adolescents with IBD. Positive results of this trial will have a significant impact by providing initial evidence for a clinical tool that can be disseminated and implemented broadly to support self-management in underserved youth with IBD, who would not otherwise receive evidence-based self-management support.